Research Education Component

Research Education Component (REC): Project Summary
The long-term objective of the Research Education Component (REC) is the establishment of a cadre of well-
trained, highly motivated junior faculty who will become leaders and mentors in scholarship on frailty and aging
and its translation to maintain independence, health and robustness for older adults. The REC accomplishes
this objective through four specific aims: 1) It provides an education program combining subject-area,
methodological and leadership training together with mentorship having both team-based and one-on-one
elements and a mentored research project, so as to promote, benchmark, and assure research progress and
career development. 2) It partners with the Leadership Council to identify, attract, and select outstanding junior
faculty from a diversity of disciplines with the interest and potential to become future scholarly leaders on frailty
and aging. 3) It provides the research infrastructure, salary support and protected time essential to enable the
selected trainees to successfully bridge the critical transition to independent grant funding. 4) It creates a
welcoming academic home and ‘stimulus zone’ for junior faculty, postdoctoral fellows, and predoctoral students
invested in frailty-related scholarship through a variety of forums for ongoing networking and intellectual
enrichment where they can interact with each other together and senior OAIC faculty. Forums provided
complement structured mentorship plans for supported faculty and include monthly sessions in which REC-,
PESC- and DP-supported faculty present research-in-progress, twice-monthly meetings of the Frailty and
Multisystem Dysregulation research working group, and sponsorship of other working group meetings,
seminars and guest lectures in collaboration with partnering institutional resources on aging. REC-supported
faculty receive full mentorial and material support from each resource core, as appropriate to their interests
and needs. Information dissemination infrastructure overseen by the LAC provides supported faculty with
avenues by which to disseminate their findings. Resources are prioritized, first, to K-eligible individuals,
followed by R-eligible individuals and then to other trainees so as to direct Core efforts to provide support at a
key transitional point, when research careers are often in jeopardy because of lack of funding and research
infrastructure. The leadership of this Core and the OAIC as a whole will continue to emphasize training across
disciplines and that bridges basic science and clinical investigation. Demographic diversity and inclusion are
prioritized: A new working group will help us ascend yet further in this area. The overall approach we propose
has achieved notable success as evidenced by the accomplishments and success in receipt of career
development awards of previously supported faculty.